The ECOG-ACRIN SUPPORT Trial: Multilevel Intervention to Improve Diverse Enrollment in Cancer Clinical Trials

ABSTRACT
Inadequate diversity in clinical trials is widely recognized as a significant contributing factor to health disparities
experienced by racial/ethnic minorities and other diverse populations in the US. This lack of parity calls for urgent
initiatives aimed at increasing diversity in order to support more equitable representation in clinical research and
bring the benefits of advances in healthcare forged by clinical research equitably to all. National Cancer Institute
(NCI) supported clinical trials (CTs) are key drivers of innovations in cancer care; however racial/ethnic
minorities, and Black and Latino populations in particular, are underrepresented in NCI-supported CTs and thus
not able to fully benefit from cutting edge treatments and precision medicine. CT participation among Black and
Latino populations continues to fall short and the multitude of structural, clinical, physician, and patient barriers
warrant multilevel interventions to enhance referral and enrollment of Black and Latino patients to NCI-supported
CTs. The ECOG-ACRIN Cancer Research Group (EA), as an NCORP Research Base, has engaged community
providers and researchers through a robust research portfolio that spans Cancer Control, Cancer Prevention,
and Cancer Care Delivery. We propose to leverage the collective resources of the EA, our team’s decades of
work on improving diversity in clinical trials, and our foundational work in patient navigation and CT research
literacy tools to create and evaluate an ECOG-ACRIN Trial SUPPORT Toolkit (SUPPORT intervention) that aims
to improve Black and Latino referral and enrollment in active NCI-supported therapeutic trials in head and neck,
thoracic, and genitourinary cancers, and leukemia and myeloma. The multilevel EA SUPPORT intervention
consists of a CT research literacy tool and CT Resource Navigators based at EA who will interface with patients,
providers, and community oncology site staff to improve referral and enrollment of Black and Latino patients to
CTs. Our specific aims are to: 1) Conduct preliminary assessments and refine the EA SUPPORT intervention
with focus on community representation and input. 2) Conduct a Hybrid Type 1 cluster-randomized, roll-out
effectiveness-implementation trial in 10 NCORP community oncology practice sites (with N= 500 Black and
Latino patients with cancer) to evaluate the effectiveness of the EA SUPPORT intervention in improving Black
and Latino patient referral and enrollment to NCI-supported CTs (primary outcomes) and participant and provider
awareness and knowledge of CTs (secondary outcomes) while assessing implementation factors. 3) With the
CUSP2CT Data, Evaluation, and Coordinating Center, conduct final site evaluation and disseminate the
SUPPORT intervention to NCORP community oncology sites, research bases, and affiliated trial networks. Our
collaborative infrastructure and EA SUPPORT multilevel intervention will shift the current clinical trial research
base referral and enrollment paradigm and directly remove multiple levels of barriers through innovations in CT
navigation and CT research literacy tools.

Public health relevance
PROJECT NARRATIVE Clinical trials (CT) participation by underrepresented populations continues to fall short, and the multitude of structural, clinical, physician, and patient barriers call for multilevel interventions to enhance referral and enrollment of Black and Latino patients to National Cancer Institute (NCI)-supported CTs. Building on the extensive resources of the ECOG-ACRIN Cancer Research Group (EA) and our team’s expertise in patient navigation research, community engagement, racial/ethnic minority clinical trials enrollment, and implementation science, we will develop a multilevel EA SUPPORT intervention (consisting of a CT Research Literacy Tool and CT Resource Navigators) to increase referral and enrollment of Black and Latino cancer patients to NCI- supported CTs.